BIOPHYSICAL INSTRUMENTATION AND METHODOLOGY

The project is designed to develop new instrumentation and methods and to improve existing instrumentation and techniques for the characterization of biological macromolecules and for study of their interactions. Analytical ultracentrifugation, the techniques ancillary to it, and methods of data analysis using mathematical modeling appropriate for these techniques are the major areas of interest. Studies on the application of mathematical modeling to problems of ultracentrifugal analysis have been continued. The applications of these studies are described in the project report 10184-05. Major progress has been made in the development of data acquisition systems. A data acquisition system using the IBM XT computer has been completed and successfully tested and a similar, but more sophisticated and flexible system using the Macintosh II is nearing completion. New methods of performing experiments and analyzing data have been developed and work is continuing in this area. Feasibility studies toward the development of fluorescence scanning data acquisition systems of very high sensitivity have been continued.